Pulmonary Development and Disease Pathogenesis Training Program

PROJECT SUMMARY/ABSTRACT
The Pulmonary Development and Disease Pathogenesis T32 Training Program provides advanced research
training through stipends for five predoctoral and three postdoctoral candidates within the University of
Cincinnati College of Medicine (UCCOM) and Cincinnati Children's Hospital Medical Center (CCHMC). Our
training environment leverages established, integrated, and innovative graduate and postgraduate programs in
molecular, developmental, and cell biology, alongside exceptional clinical and translational programs focusing
on pediatric and adult pulmonary diseases and radiological imaging research. Supported by robust NHLBI-
funded research programs, the T32 initiative brings together over 38 distinguished NIH-funded investigators with
expertise in molecular and cell biology, physiology, and imaging strategies to study lung development and
diseases. The program's faculty engage in shared research interests and active collaborations in both basic and
translational research, with major themes including the genetic, cellular, and molecular basis of pulmonary
disorders across the lifespan. Key areas of expertise include pulmonary cell interactions during lung
morphogenesis and regeneration, mechanisms of branching morphogenesis, alveologenesis, repair processes,
and the genetic basis of lung diseases. Additional strengths encompass research in biomarkers, imaging, and
therapeutic approaches for pulmonary parenchymal and vascular diseases. Promising pre- and postdoctoral
trainees are selected on a competitive basis. Ph.D. and MD/PhD predoctoral trainees pursue their degrees in
Graduate Programs in Developmental Biology, Immunobiology, Biomedical Informatics, Pathobiology, and
Molecular Medicine. Postdoctoral trainees who may hold MD, PhD, or combined MD/PhD degrees are recruited
into T32 Mentor laboratories. The program places special emphasis on recruiting minority individuals and
physician-scientist candidates pursuing MD/PhD training. Research training is comprehensive, including
mentorship in career development, responsible conduct of research, scientific rigor, ethics, research presentation
skills, and participation in seminars and courses across graduate and divisional programs. Trainees are actively
engaged in research meetings and relevant seminar series. Program administration consists of the Contact Co-
PI, three Co-Principal Investigators, an Executive Committee, and both External and Internal Advisory
Committees. Rigorous oversight includes regular assessments of trainee progress, mentor quality, and overall
program effectiveness. Trainees meet frequently with their mentors, the T32 Program Director, and Co-Directors
quarterly, and their Mentoring Committee at least biannually. This T32 renewal application (Years 30-35) seeks
to continue the program's tradition of excellence, fostering the next generation of investigators to enhance
research training and expertise in critical aspects of pulmonary development and disease.

Public health relevance
PROJECT NARRATIVE This renewal application for the T32 grant aims to continue support for the Pulmonary Development and Disease Pathogenesis Training Program, which recruits and trains exceptional pre-doctoral and post-doctoral candidates to drive scientific advancements and make groundbreaking discoveries in pulmonary disease diagnosis and treatment. Our program is distinguished by its focus on developmental and regenerative processes, offering a unique, interdisciplinary training environment that integrates pediatric and adult pulmonary programs with basic and clinical sciences. There is an ever-increasing loss of M.D. and Ph.D. candidates from academic-scientific careers at a time in which unparalleled opportunities exist to identify underlying disease pathogenesis mechanisms and develop novel biomarkers, diagnostics, and treatment strategies to improve human health.